Structural Insights into Leucine Transport for mTORC1 Activation

Project Summary/Abstract
The mechanistic target of rapamycin complex 1 (mTORC1) pathway is a gatekeeper that balances anabolic and
catabolic processes through sensing nutrients. Dysregulations of this pathway lead to debilitating diseases such
as cancer. One of the most abundant essential amino acids in cancer cells is leucine. However, the process of
leucine sensing and transport to activate mTORC1 pathway is not clear. The lysosomal associated
transmembrane protein (LAPTM4b) is an oncoprotein that is involved in localizing leucine transporter to the
lysosomal surface to activate mTORC1 pathway. LAPTM4b also functions as a ceramide transporter and
compartmentalizes ceramide to help cancer cells evade apoptosis. Currently, there is no high-resolution
structure of this protein to elucidate its mechanism of ceramide transport and complex formation with the leucine
transporter. It is paramount to explore the structure and functions of LAPTM4b in detail since more than ~70%
of cancers have LAPTM4b upregulation and LAPTM4b has been linked to poor prognosis.
This proposal focuses on understanding the structure and functions of LAPTM4b and its protein complexes to
lay the foundation on mTORC1 activation through leucine. The structures will be solved using state-of-the-art
cryogenic electron microscopy techniques including Microcrystal Electron Diffraction (MicroED) and Single
Particle Analysis (SPA). In Aim 1, the mechanism of ceramide binding in LAPTM4b will be elucidated by high
resolution structures of LAPTM4b in complex with ceramide using MicroED. The structures solved in this aim
will provide insights on the effect of ceramide to the global confirmation of LAPTM4b and provide basis on
structure guided drug development. Functional studies of LAPTM4b in complex with the leucine transporter in
liposome assays will be investigated in Aim 2. Kinetics of leucine transporter will be evaluated in vitro to provide
insights into how LAPTM4b, ceramide, and ceramide analogues affect leucine transport. In Aim 3, the structure
of the protein complex of LAPTM4b and the leucine transporter will be solved to understand their interactions
and guide drug development to disrupt this complex for mTORC1 inactivation.
The applicant’s career goal is to use tools in structural biology combined with biochemistry experiments to answer
scientific questions on disease-related proteins. Since there is an urgent public health need to alleviate cancer,
the applicant aims to study challenging membrane proteins involved in the mTORC1 pathway. The structure-
function relationship of these proteins will guide future research on designing effective cancer therapeutics to
disrupt this pathway. The proposed research is an integral step of the applicant’s career path. The applicant will
receive intensive training and constructive guidance under a leading researcher in the structural biology field.

Public health relevance
Project Narratives The proposed study will utilize cryogenic Electron Microscopy (cryoEM) techniques and biochemical experiments to understand the structure and function of oncoprotein LAPTM4b. The invaluable results will provide the first mechanistic insights of this protein in cancer cell proliferation. The results from the proposed study will guide structure-based cancer drug development and advance the field for better therapeutics.